Chemically Precise Framework Materials as a Modular Platform Technology for Electroanalysis

Engineered tissue holds tremendous promise for improving health and quality of life of patients
suffering from trauma, illness, or organ failure. Realizing the full benefits in tissue engineering
requires improved fundamental understanding of homeostasis, metabolism, inflammation, and
nutrient transport in engineered tissue, coupled with reliable and integrated quality control during
the manufacturing process. By virtue of being modular, portable, capable of operating in real-time
environments, as well as being amenable to non-invasive and label-free formats, a chemical
quality control based on electroanalysis offers one plausible solution to this challenge. However,
current electroanalytical devices do not allow for selective in-situ continuous chemical monitoring
and reporting of performance in engineered 3D tissue scaffolds within enclosed bioreactors.
Enabling the study of chemical processes of engineered tissue requires radically new sensing
materials with improved chemical sensitivity, selectivity, chemical stability capable of
straightforward integration with 3D tissue scaffolds.
The overarching goal of this research is to develop conductive metal-organic frameworks
(MOFs) and covalent organic frameworks (COFs) as multifunctional sensing materials with broad
potential utility in electroanalysis. The proposed technological approach to chemical detection
offers unprecedented ability to generate atomically-precise electronic materials and devices with
chemically-tunable electroanalytical performance. This MIRA application leverages bottom-up
synthesis and self-assembly to develop sensitive and selective non-enzymatic porous working
electrodes for gasotransmitters (CO, NO, H2S), nutrients and metabolites (glucose and lactate),
and neurochemicals (ascorbic acid, uric acid, dopamine, and serotonin).
The research plan implements a multidisciplinary approach comprising chemical synthesis,
spectroscopic characterization, device integration, and electroanalysis to achieve three
hierarchical levels of chemical control in molecular engineering of framework materials for
chemical detection: (1) Atomic-level control of host-guest interactions through solvothermal
synthesis and self-assembly; (2) Nanoscale control through morphological tuning of surface
electrocatalysis; (3) Epitaxial control of electrochemical interfaces within solid-state, porous, and
flexible devices. Conceptual and technological advances emerging from this work will serve as a
vehicle to develop the proposed materials into novel components of future electroanalytical
devices with transformative potential in tissue engineering, biomedical analysis, and patient-
centered mobile healthcare.

Public health relevance
This proposal describes a novel technological approach towards portable electroanalysis that merges modular chemically-precise sensing materials with seamless device integration on porous and flexible substrates. The molecular design relies on conductive porous scaffolds that serve as ultra-sensitive hosts and transducers for physiologically-relevant guests within electronic devices. Conceptual and technological advances emerging from this work will enhance the development of modular bioanalytical systems with potential impact in monitoring quality control of engineered tissue and wearable electronics.